B cell dynamics and immune memory formation in human vaccination

PROJECT SUMMARY
Vaccination prevents millions of deaths each year by generating protective immunological memory against
pathogens, mediated by long-lived memory B and plasma cells. Diverse B cell populations emerge after
vaccination, including CD11c+CD21lo atypical B cells, which are primed for plasma cell differentiation and
antigen presentation. However, the relationships between early vaccine-responsive B cell subsets and the
long-lived memory B and plasma cells that provide durable immune protection have not been established in
humans. Further, novel immunostimulatory adjuvants increase the durability and breadth of vaccine responses,
but head-to-head comparisons of their effects on human B cell differentiation are lacking. Insufficient
knowledge of the functional relevance and relationships among human B cell subsets and how they are
modulated by adjuvants impedes the rational design of vaccines to induce protective immunological memory.
Here, we will systematically interrogate human B cell, plasma cell, and antibody responses after HIV
vaccination and dissect the mechanisms of their induction in a human immune organoid model. Our unique
vaccine cohort is comprised of four groups receiving the same immunogen with a different adjuvant and
includes sampling of lymph nodes, where memory B and plasma cells differentiate from germinal center B
cells, and bone marrow, where long-lived plasma cells reside. I hypothesize that the adjuvant, 3M-052-AF, will
direct atypical B cells towards a germinal center fate, yielding more potent and durable antibody responses. To
test this hypothesis, I will leverage our team’s extensive expertise in human B cell biology, vaccinology, and the
application of antigen-specific systems immunology tools.
I aim to: (1) identify which vaccine-response B cell populations are clonally related to long-lived populations
and predict durable immune responses; (2) evaluate the influence of four adjuvants on B cell and antibody
responses; and (3) determine the impact of adjuvant on cell phenotype, germinal center organization, and B
cell receptor repertoire in a human immune organoid model.
To achieve these research aims and establish myself as an independent investigator, I have devised
complementary career development goals: (1) expand B cell biology domain knowledge and scientific network;
(2) develop expertise in human immune organoid experimentation; and (3) cultivate skills necessary to lead an
independent research group. My mentors are Dr. Evan Newell, a systems immunologist, and Dr. Julie
McElrath, Director of the HIV Vaccine Trials Network Laboratory, and my advisory committee is comprised of
experts in B cell biology, immune organoids, vaccinology, and computational biology. This adept team will
provide guidance on both research aims and career development goals, complementing a series of workshops
and courses that I have identified to develop the skills and knowledge to lead my own research group.

Public health relevance
PROJECT NARRATIVE Vaccination prevents millions of deaths each year by generating protective immune memory against viruses or bacteria. Most of what we know about the long-lived immune cells that provide this protection has been learned from studying mice, but the many differences in human and mouse biology have limited our ability to translate mouse research findings into human vaccination strategies. We are now applying a broad range of cutting- edge experimental techniques to rigorously analyze how human immune cells generate immune memory after vaccination and how that immune memory formation can be improved by including different vaccine components.